Diversity Administrative Supplement to Maximizing Flexibility: Optimized Neural Probes and Electronics for Long Term, High Bandwidth Recordings

Project Summary No changes from original grant U01NS115588

Public health relevance
Project Narrative No changes from original grant U01NS115588